METHADONE EFFECTS ON AZT DISPOSITION

The specific aim of this study is to identify and characterize the effects of methadone maintenance on the disposition of AZT. Preliminary data provides evidence of a pharmacokinetic interaction between the two drugs.